Microbiome-induced changes following influenza infection during pregnancy

Project Summary
Influenza A virus (IAV) impacts pregnant individuals and their offspring to a greater extent than the
general population during pandemics and seasonal epidemics. Pregnancy is a risk factor for severe outcomes
from IAV infection, including increased risk of hospital admission and death, and is also associated with
adverse perinatal and fetal outcomes. While IAV does not replicate in the placenta, IAV infection induces
placental damage and inflammation, which can be mitigated using steroids and result in reversed perinatal
outcomes in a mouse model. The maternal gut microbiome is crucial in maintaining physiological homeostasis
during pregnancy, but how virus-induced dysbiosis contributes to adverse fetal outcomes is unknown. I
hypothesize that adverse fetal outcomes, including intrauterine growth restriction, may be enhanced by IAV-
induced changes in the diversity and composition of the maternal gut microbiome. The goal of this project is
to investigate the mechanisms by which the maternal gut microbiome contributes to adverse fetal and
perinatal outcomes using an outbred pregnant mouse model of IAV infection. My preliminary data show
that IAV infection reduces maternal fecal microbial diversity and bacteria associated with short-chain fatty acid
(SCFA) production, which is associated with intrauterine growth restriction and developmental delays in
offspring. The central hypothesis of this proposal is that placental damage, inflammation, and
intrauterine growth restriction during IAV infection of pregnant dams are caused by changes in the
maternal gut microbiome, which increases intestinal barrier permeability, reduces the production of
microbial metabolites (SCFA), and enhances intestinal inflammatory immune cell populations. Utilizing
my previous experience in clinical bacteriology and recently developed expertise with mouse models of
pregnancy, Aim 1 will focus on characterizing changes in intestinal morphology, microbial metabolites, and
intestinal immune cell populations after IAV infection. Aim 2 will investigate the direct effect of IAV-induced
maternal gut dysbiosis on adverse perinatal outcomes using fecal-microbial transplantation. If changes in the
maternal gut microbiome contribute to adverse fetal outcomes after IAV infection, then probiotic
supplementation will reduce placental damage, inflammation, and intrauterine growth restriction. The research
aims outlined in the proposal will assist in continuing my training in animal models, viral immunology, and
microbiome-based experimental manipulations, further enhancing my expertise in the relationships between
viral pathogens and native host bacteria.

Public health relevance
Project Narrative Influenza A virus (IAV) infection can cause severe disease during pregnancy, resulting in hospitalization and developmental delays in children. Using microbiome-based experimental manipulations, the hypothesis that IAV-induced changes in the gut microbiome contribute to placental damage, inflammation, intrauterine growth restriction, and adverse fetal outcomes will be tested in a mouse model. The effect of IAV-induced maternal gut dysbiosis on the placenta through morphological and immune response changes in the intestine will be explored, which could provide insight into potential therapeutics (e.g., probiotics) for mitigating adverse effects of respiratory viral infections during pregnancy.